Duke CTSA

The mission of the Duke Clinical and Translational Science Institute is to catalyze the translation of scientific
discoveries into population health benefits through collaborative research. With previous Clinical and
Translational Science Award (CTSA) funding, we have successfully developed infrastructure and provided
resources to support investigators across the clinical and translational scientific and workforce spectrums. Our
achievements have facilitated high-impact discoveries, increased research efficiency, and nurtured a more
capable and diverse workforce. We have also ignited a new era of collaborative science at Duke. Several new
transdisciplinary programs have been launched, connecting trainees and faculty from our Schools of Medicine,
Nursing, Engineering, Business, and Arts and Sciences to enhance translation. In the next phase, Duke
proposes to capitalize on new opportunities with three broad initiatives. First, we will optimize clinical and
translational science national networks’ methods and processes. Building on Duke’s leading experience
coordinating multi-center clinical trials including its national Duke-Vanderbilt NCATS Trial Innovation Center,
we will develop methods to optimize ‘local hub,’ ‘hub-to-network’ and ‘network-to-network’ processes for the
NCATS Trial Innovation Network. We will also help investigators leverage a number of additional NIH network
resources and provide methods to disseminate best practices throughout the CTSA network. Second, we will
deepen, nurture, and extend stakeholder collaborations. We will strengthen existing partnerships and foster
new ones with stakeholders at both the institutional and investigator levels. Partnerships and programs will
expand the breadth and transparency of CTSI activities. We will also support investigators’ greater
engagement with a broad range of patients, community groups, clinicians, health care systems, industry,
venture capitalists, payers, policy makers, and others. Third, we will catalyze further science integration at
Duke. An invigorated professional workforce will facilitate major transdisciplinary science initiatives. A new
University-wide coordination infrastructure will further amplify collaboration and bridge science siloes. We will
also support teams by improving their skills in team science, studying team processes, and by promoting the
recognition of team contributions at our institution. Collectively, these activities will amplify the innovation and
impact of our research nationally, regionally, and locally. We will measure outcomes that reflect improvement
in the translation of discoveries, use of national best practices, institutional and investigator teamwork,
research transparency, and community trust. We will share all best practices with the CTSA network. We
believe our achievements will meaningfully enhance the impact of clinical and translational science on health
across the United States.

Public health relevance
The Duke Clinical and Translational Science Award (CTSA) will help science discoveries made at Duke University and collaborating institutions provide maximum benefit to the United States population. It will develop new methods, programs, and training to ensure Duke scientists and teams are able to improve health efficiently and with the greatest impact possible. The Duke CTSA efforts will improve the health of the public locally, regionally, and across the nation.